Training and Dissemination Core

Training & Dissemination Abstract
To support its Training & Dissemination goals, the Center for Mesoscale Mapping (CMM) calls on a broad range
of outreach and training programs and modes of dissemination, building on those established by the MGH
Martinos Center. The outreach and training efforts encompass a host of different programs at both the local and
the national level. Locally, this effort involves directly engaging graduate students, postdoctoral trainees and
faculty in the TR&D Projects and partnering with established training, education and mentorship programs within
and outside the institution, including at Massachusetts Institute of Technology (MIT). For this renewal, we will
add a new hands-on module to the MIT courses taught by CMM faculty, with a focus on educating and making
available the cutting-edge tools developed in the CMM to the researchers who audit our training courses. By
actively engaging graduate students, postdoctoral fellows and young faculty in TR&D (and CP/SP) research, the
CMM supports career development and provides intensive, hands-on training for the next generation of basic
and clinical neuroimaging researchers and ensures the long-term growth of the CMM. Nationally, by offering
courses and workshops such as the long-running fMRI Visiting Fellowship, the Connectivity Course (Connectivity
Course: Structural and Functional Brain Connectivity via MRI and fMRI), the Freesurfer Workshop and a Coil
Building Workshop to be hosted by the Martinos Center’s new MakerSpace and Rapid Prototyping Lab, the CMM
will ensure that opportunities to learn the technologies developed by its faculty extend beyond these local groups
to a larger community of geographically distributed users at all career stages. Its dissemination activities are
similarly wide-ranging. Knowledge gleaned from CMM research will be disseminated through conventional
means (papers and presentations), remotely viewable seminars including the CMM-sponsored BrainMap series,
a Mesoscale Symposium introduced last year and slated to be held throughout the renewal period, and a robust
web and social media presence. Technology dissemination will take advantage of open-source sharing of
software and hardware documentation, including through a portal on the CMM website. To further extend the
impact and broad use of CMM technologies, we will also continue to work with companies to provide commercial
access to hardware and software tools, including all interested industrial parties from small SBIR-supported
companies to the largest industrial partners like Phillips, General Electric, and Siemens to license both our
hardware and software innovations.